Biostatistics Core

PROJECT SUMMARY
The Biostatistics Core will provide the timely and high-quality statistical support necessary for the success of
the Program Project. The Biostatistical support will center on three specific aims: 1) provide support for the
design, analysis and proper inference from the laboratory and patient sample studies conducted in the
Projects, 2) apply state-of-the-art statistical tools to gain additional insights into data created in the Projects
and 3) provide support for combining data from multiple sources. The general analysis principles include
methods to validate assumptions; improve precision by removing known sources of variation, such as
experiment to experiment variability; control for multiple hypothesis testing; and validate models. The data and
programming support will provide expertise in merging data from multiple sources and archiving data to allow
the results of data analyses to be preserved and reproduced. Biostatistics support is critical for the success of
the Program Project. The Biostatistics Core provides easy and guaranteed access for investigators and also
allows the biostatisticians to specialize in the Project areas regarding content knowledge and appropriate
statistical methodology. A dedicated Core provides timely and high-quality biostatistical services as its focus.

Public health relevance
PROJECT NARRATIVE Biostatistics and data management support are critical for the success of the Program Project, which involves human subjects, animal models, and approximately 30 different hAML cell lines. The Biostatistics Core provides easy and guaranteed access for investigators and also allows the biostatisticians to specialize in the Project areas regarding content knowledge and appropriate statistical methodology. The dedicated and experienced personnel in the Core provide the resources and support available to all investigators in the Program Project, and the Core serves as the interface to the larger resources in biostatistics in the Department of Public Health Sciences (DPHS) of the School of Medicine at the University of Virginia.